The Penn Center for Career Development in Women's Health Research

Project Summary
The Penn Women's Reproductive Health Research Career Development Program seeks continued support to
recruit, train, mentor and nurture the next generation of obstetrician-gynecologists destined for careers as
physician investigators and leaders in academic medicine. The program is designed to provide guidance and
support to Scholars to allow for the transition to productive, innovative and funded careers as independent
investigators. To accomplish our goal, we develop individualized research and career development programs,
utilize team mentoring, provide support for bioinformatics and biostatistics, and encourage participation in
courses in translational medicine and epidemiology, seminars, and specialized workshops to support
academic, research and leadership growth. The Penn WRHR Center builds on a tradition of multi-faceted
investigation and training in reproductive biology and women's health in the Department of Obstetrics and
Gynecology dating back to 1964. The department and the Center for Women's Health and Reproductive
Medicine are an integral part of Penn's exceptional biomedical research enterprise, ranking among the top in
the nation, with numerous clinical, basic, and translational research opportunities, outstanding research
facilities, faculty and infrastructure, and educational programs to foster the development of young physician
investigators. With support from the department chair and the School of Medicine, and guidance from the
Research co- Directors and Recruitment Officer and teams of experienced mentors from the department and
relevant Centers and Institutes across the Penn campus, the Scholars will advance their knowledge and
research skills to be well-positioned to conduct independently funded, innovative research in women's health.
The Penn WRHR Center has provided a mentored research experience and career development program that
has inspired our Scholars to remain in academic medicine and establish highly productive, funded research
programs. Of the 16 Scholars enrolled in the program, 14 have completed it and 2 are currently active. The 14
graduates all have an exemplary record of scholarship and leadership and the research productivity and
sustained funding of 11 of them have been exemplary. They have received multiple federal research grants
including R01s and R01-equivalents. In fact, in EVERY clinical division in our department there are MD
Ob/Gyn physician investigators with R01 grants. Most of these investigators have been K awardees including
WRHR scholars. In addition, most of our WRHR graduates are members of NIH study sections and journal
editorial boards, and most are serving in leadership positions at Penn or at their current institutions and with
their respective professional organizations. The Penn WRHR Center's philosophy, approach, and ability to
provide a supportive environment that embraces trans-disciplinary investigation, and discovery will continue to
prepare Scholars for careers as physician investigators and leaders in academic obstetrics and gynecology.

Public health relevance
Project Narrative The Penn WRHR Center will encourage and foster the development of academic obstetrician gynecologists in order to contribute to the improvement of the health of women and their children.